ASSESSING OUTCOMES OF HEALTH SYSTEM SUICIDE RISK SCREENING PROGRAMS

To uncover insights on the impact of suicide screening program and to identify new opportunities for suicide prevention. Will conduct analysis to determine and compare rates of non-fatal self-inflected injuries and rates of suicide among screened patients.